Clinical and Translational Science Collaborative of Northern Ohio, CTSA Postdoctoral T32 at Case Western Reserve University

Clinical/Translational (C/T) scientists who conceptualize health problems in new ways and utilize skills that
both enhance interdisciplinary work in clinical and community settings and catalyze translational processes are
vital to address the nation’s unmet health needs and achieve equity in health care. Building upon the
successes of our existing C/T training programs for predoctoral students, post-doctorates, and junior faculty,
and in collaboration with the Workforce Development and Community & Stakeholder Engagement Modules of
our Clinical & Translational Science Collaborative, our Clinical and Translational Scientist Training Program for
Post-doctorates (CTSTP-Post) will enable a diverse cadre of postdoctoral trainees to both ‘deepen’ their
scientific domain expertise and develop the knowledge, perspective, and skills necessary to function efficiently
and effectively as C/T scientists facing the opportunities and challenges of medicine and health in the 21st
Century. We will also increase diversity in trainees and create a research environment welcoming to that
diversity. Strategic partnership with Historically Black Colleges and Universities (HBCU) and other targeted
institutions will increase the number of underrepresented minorities, persons with disabilities, and persons from
disadvantaged backgrounds in our training program and, ultimately, into the C/T Science workforce. Through
this program, twelve trainees will each complete a two-year appointment. Using a strategic combination of
training activities – e.g., mentoring by a successful, experienced C/T scientist, coursework, observerships and
other field experiences, workshops, symposiums, seminars/discussions – trainees will acquire deeper
understanding of and sharpen their skills in translational processes, interdisciplinary research, team science,
communication, systems science and complexity, community and stakeholder engagement, innovation,
entrepreneurship and commercialization, dissemination and implementation science, information science and
artificial intelligence, health disparities, professional and leadership development, responsible conduct of
research, and methods for enhancing reproducibility. Our program will interact with the proposed CTSTP for
Predoctoral Students and K12 Program for Junior Faculty, creating a rich culture of learning and exchange,
where perspectives of different disciplines are represented and where trainees share ideas, challenge each
other, and grow together. Although each program will be distinct and will have its own Internal Advisory
(Steering) Committee and unique components, oversight of all three programs by a single Research Education
Advisory Board, a shared mentor pool, strategically selected joint activities, and standardized evaluation
approaches and tools will create synergies in training, leadership, and management across programs and
assure attainment of program objectives.

Public health relevance
The process of developing new medical treatments, new tests to detect disease, and new medical devices requires researchers with a special set of skills. The purpose of this training program is to provide these special skills to a diverse group of early-career researchers so that they can be more effective scientists and have a positive impact on public health in any educational or industry setting they work.